Dissecting the Cognitive Roles of Hippocampus and Other Temporal Lobe Structures in Patients Undergoing Epilepsy Surgery

Project Summary:
We have conducted the largest prospective comparative study of laser amygdalohippocampotomy (SLAH), a
minimally invasive procedure ablating the amygdalo-hippocampal complex (AHC) versus selective and standard
open resection (OR) epilepsy surgery (N=425+). We demonstrated that SLAH is superior to OR in 1-year
cognitive outcomes in adults (including episodic verbal memory & perceptual (semantic) recognition or name
retrieval of objects/faces), while achieving comparable seizure control. We will extend our analysis
longitudinally in an unprecedented manner (5-10 year outcome) leveraging this unique cohort of well-studied
patients including neuropsychological (NP), structural and functional neuroimaging and seizure outcomes.
We have also amassed a large sample of cases involving stereotactic laser ablation [SLA] of non-AHC
structures. The heterogeneity of these SLA cases and the focal nature of the laser ablation surgical zones create
an amazing opportunity for lesion-behavioral analyses. We will expand our neuroimaging analyses to include
rigorous voxel lesion symptom mapping (VLSM) and novel methods of connectivity modeling with diffusion
tensor imaging and resting state fMRI. We will focus on the neural circuitry responsible for declarative memory
and language, while determining the optimal surgical zones to produce the best long-term cognitive and seizure
outcomes. VLSM allows us to determine which temporal lobe regions are critical for specific cognitive
functions, while connectivity analyses will reveal the interconnectedness of these regions in the individual
patient (allowing us to determine the relative risk of decline at the patient level).
Our preliminary findings indicate that: 1) SLAH patients exhibit unexpected improvement in multiple
cognitive functions, which is unparalleled in their OR counterparts, and 2) SLA procedures sparing the AHC
and broader medial TL regions frequently lead to severe decline in verbal memory/naming, particularly in
cases of focal ablations of the language dominant temporal pole or fusiform gyrus. This suggests that verbal
declarative memory depends upon a broad network extending beyond the AHC, which is a paradigm shift for
surgical planning (i.e., regions thought to be expendable during surgical approach are actually critical to
function). This knowledge is fundamentally important from mechanistic and clinical translational points of
view, and our data and planned analyses provide a unique and feasible way to draw robust conclusions on these
long-standing knowledge gaps. Our data raise pivotal questions about existing declarative memory models and
the mechanism of recovery underlying the superior cognitive outcomes in many SLAH/SLA cases (e.g.,
functional sparing vs. reorganization), which we will address in this renewal by following our patients over
time. Finally, while more epilepsy centers are employing SLA due to its improved cognitive outcomes, ultimate
clinical adoption rests on seizure control, making it critical to determine SLAH efficacy over a longer time span.

Public health relevance
Project Narrative: We carried out the largest prospective study of laser ablation and traditional open resection (OR) epilepsy surgery techniques using neuropsychological testing and neuroimaging completed at pre- and 1-year post- surgical time points (N=425+), and will now assess moderate term (5-10 year) outcome for all subjects with regards to seizure freedom, and cognitive and functional recovery (i.e., changes in ability to work, live independently). Preliminary data lead us to predict far better longitudinal cognitive and functional recovery for laser ablation patients, and has led us to question the validity of existing models of the brain regions involved in verbal memory and language. We will use advanced neuroimaging techniques to guide surgical practice (i.e., extent and location of ablation/resection) and outcome prediction at the level of the individual patient, while improving our knowledge of the neural circuits underlying cognition.